Early diagnosis and mechanistic studies of type 1 diabetes using single cell analysis

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
No change

Public health relevance
Type 1 diabetes (T1D), a prototypic CD4 T cell mediated autoimmune disease, is believed to have a prolonged pre-clinical phase that lasts many years. We will use circulating anti-insulin CD4 T cells as a real-time biomarker of islet autoimmunity to diagnose subclinical disease in at-risk population and decide of therapeutic intervention. The proof of principle of this approach has been established in a small cohort of patients enrolled in the TrialNet consortium.